Neural Circuit Mechanisms of Stress-Impaired Social Reward

Abstract:
Traumatic social experience in humans can impair brain reward function leading to severe social avoidance.
Rodent stress models such as chronic social defeat stress (CSDS), can also cause severe social-avoidance
mediated, in part, through altered reward circuit function. One of the prominent questions arising from such
rodent studies is whether such social avoidance behaviors occurs due to a loss of social reward or preference.
Using a standard CSDS model, we measured social interaction with threatening (aggressive CD-1 mice) and
non-threatening (same sex 3-week old juvenile C57BL6/J mice) social target mice. We find that CSDS leads to
social avoidance to both threatening and non-threatening social targets in a subset of male and female mice
termed susceptible. Control and resilient mice do not exhibit social avoidance to either target mouse. To
measure social reward, we utilized a social conditioned place preference (CPP) assay, where experimental mice
were conditioned with a same sex 3-week old juvenile C57BL6/J. We find that that CSDS impairs formation of
social CPP in susceptible, but not resilient, male and female mice. We next used whole brain iDisco clearing and
c-Fos mapping following juvenile social interaction in CSDS-exposed mice and found several brain regions with
increased c-Fos expression specifically in susceptible mice. The lateral septum (LS)—a stress responsive brain
region—was highly activated in susceptible mice, but not resilient or control mice. We performed in situ
hybridization to identify specific cell types in the LS and found a neurotensin (LSNT) positive GABAergic
population activated during juvenile social interaction only in susceptible mice. We next utilized in vivo fiber
photometry and GCAMP6-mediated Ca2+ imaging along with and chemogenetics to confirm that LSNT neurons
are activated in real-time during juvenile social interaction and they regulate social avoidance and social CPP.
To determine downstream LSNT connections, we used predicted correlation matrices from iDisco c-Fos
expression maps to identify functionally connected regions and then confirmed these connections with viral
tracing tools and optogenetics. We found a functional connection between LSNT neurons and the nucleus
accumbens shell/nucleus of the diagonal band that regulates social interaction. Our research provides a circuit-
level framework to understanding deficits in social behavior, that are common among many stress-related
illnesses, such as depression.

Public health relevance
Narrative: Social stress in humans increases the risk for depression resulting in anhedonia—a loss of interest in pleasurable stimuli—which can manifest within social domains and lead to severe social impairments. Mouse models of social stress are useful to better understand the biological underpinnings of stress-impaired social behavior deficits. Our results show that activation of lateral septum in susceptible mice following social defeat occludes social reward and preference promoting social avoidance behavior.